A population-bases atlas of the zebrafish brain for quantitative phenotypic compa

Genetically modified animal models, such as the zebrafish, are frequently employed to understand the development, genetics, and biological processes associated with human diseases. To decipher the complex genotype-phenotype relationships underlying inherited neurological disorders, the structure of the central nervous system in a transgenic model must be compared with that of wild-type animals. Anatomical methods that rely on transparency of the zebrafish are restricted to embryonic and larval animals but cannot be applied to older animals (> 6 days post fertilization), which have become opaque. Moreover, results obtained with this immature age group may not be applicable for neurodegenerative diseases with a mid- to late-life onset. Consequently, there is a growing interest in the use of mature-aged (juvenile and adult) zebrafish in studies of neurodegenerative diseases. However, a complete anatomical characterization of the mature zebrafish brain and a quantitative voxel-based probabilistic map of brain structures are needed to compare disease models with wild-type zebrafish. Recent technological developments in magnetic resonance imaging (MRI) now enable non-invasive and three-dimensional imaging of the juvenile and adult zebrafish brain. Specifically, with high- resolution T2*-weighted and super-resolution track density imaging, delineations of gross brain regions and white matter tracts are now possible at resolutions better than 10μm isotropically. Therefore we propose (1) to develop a probabilistic atlas of the wild-type (AB) zebrafish brain with high resolution T2*-weighted and super- resolution track density imaging (TDI); (2) to reconstruct histological specimens of the brain into three- dimensional volumes and to co-register these with the MR images allowing cross-referencing across modalities; (3) to create a tractographic atlas using seed points within brain regions segmented in Aim 1.

Public health relevance
This study will produce the first three-dimensional anatomical characterization of an important animal model of disorders such as Alzheimer's Disease that are major contributors to the global burden of disease. A population-based atlas of structures and fibre bundles in the wild-type zebrafish brain with normative values for parameters of tissue density and diffusion will endow future studies with the essential capability to perform voxel-based comparisons between model and wild type animals. This will allow a more comprehensive account of the effects of genetic and/or environmental manipulation on brain structure.